Exploring leaderless mRNA translation, a potential Achilles heel of mycobacteria

Project Summary/Abstract
Tuberculosis (TB) remains a significant global health threat, causing approximately 1.5 million deaths annually,
with treatment complicated by the rise of drug-resistance Mycobacterium tuberculosis (Mtb) strains. A common
target for antibiotics is the bacterial ribosome, and mycobacterial ribosomes have unique features and functions,
which may be exploited to development more effective treatments. One such example is the prevalence of so-
called leaderless mRNAs, (lmRNA) which lack the 5’ untranslated region and Shine-Dalgarno sequence used
during canonical protein translation initiation. This project seeks to develop an understanding of the mechanism
of lmRNA translation in mycobacteria and understand how this form of translation is regulated. I hypothesize that
there are unique structures in the mycobacterial ribosome that allow for efficient translation of lmRNAs and that
lmRNAs are of particular relevance during stress or infection conditions.
Aim 1 will use reverse genetics to screen candidate regulators of lmRNA translation in mycobacteria using a pair
of orthogonal reporters for leaderless translation. Regulators validated by both reporters will be further
investigated by ribosome profiling. Aim 2 will use forward genetics in the form of a CRISPRi screen to identify
unknown regulators of lmRNA translation in mycobacteria using a leaderless sacB reporter. Hits from the screen
will be validated using an orthogonal fluorescent leaderless translation reporter, and confirmed hits will be further
analyzed using ribosome profiling. Aim 3 will leverage cryoEM to identify structural components of the
mycobacterial ribosome that contribute to effective leaderless translation, first by isolating and comparing
structures of the ribosome on canonical and leaderless mRNA transcripts and later by solving structures of
ribosomes lacking promising validated hits from Aims 1 and 2. This work will allow for the identification of novel
therapeutic targets on the mycobacterial ribosome, supporting the broad NIH mission to reduce the burden of
infectious diseases.
This project combines my research interests in infectious disease, protein translation, and bacterial genetics
while increasing my familiarity with structural biology. This award will support my long-term career development
into an independent academic researcher, and I will supplement it with continued mentoring and teaching, as
well as taking advantage of the career and professional development programs available at UCSF.

Public health relevance
Project Narrative Tuberculosis (TB) remains a significant global health threat, causing approximately 1.5 million deaths annually, and the increasing number of drug-resistant Mycobacterium tuberculosis (Mtb) strains makes reducing this burden even more difficult. This project seeks to increase our understanding of a prevalent but poorly understood form of translation in mycobacteria, the translation of leaderless mRNAs. Knowledge of the mechanisms that allow lmRNA translation to occur and a deeper understanding of its contribution to the mycobacterial life cycle will contribute to the development of novel therapeutics exploiting this form of translation, increasing treatment options for drug resistant Mtb and enhancing public health.